Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Center for American Indian and Alaska Native Diabetes Translation Research (CAIANDTR) flows
administratively through the Centers for American Indian and Alaska Native Health (CAIANH) within the
Colorado School of Public Health at the Anschutz Medical Campus of the University of Colorado. It capitalizes
upon the infrastructure of the Special Diabetes Program for Indians, the Coordinating Center of which was also
located in the CAIANH until February 2019. The Administrative Core: 1) Supports logistical and field across the
Center’s Translation Research, National Resource, and Community Outreach and Engagement Cores, the
Pilot and Feasibility Program, the Enrichment Program, and academic as well as community partnerships; 2)
Oversees a management plan that stimulates, coordinates, integrates, and monitors activities and functions
across the Cores, programs, and partnerships; 3) Supervises the implementation of key strategic decisions; 4)
Facilitates implementation of research regulatory processes, data sharing plans, and timely transfer of data as
well as the dissemination of findings, and 5) Collaborates in core and program planning, review, and evaluation
to ensure Center success. The Administrative Core also supports 7 Satellite Centers that enhance outreach to,
the engagement, and full participation of key scientific, program, and community stakeholders critical to
achieving our goals. They will help translate and disseminate knowledge acquired through the Center’s work
into informed decisions about policies, programs and/or practices regarding the prevention and treatment of
diabetes and related conditions in Native communities.